Curriculum in Experimental Design and Statistics for Biomedical Researchers

PROJECT SUMMARY
For many decades biomedical research has benefitted from experimental design and statistical methods that
give studies the power to reveal underlying mechanisms and processes. In spite of their long history and
empowering role in research, experimental design and statistical principles are not well understood by
experimental biologists. Our goal is to increase the number of biomedical researchers who are fluent in
experimental design and statistics by developing a curriculum that provides both the conceptual background
and applied practice for sound and reproducible experiments. To refine this curriculum, we will test and
evaluate the curriculum with an audience of postdoctoral and predoctoral researchers at the Jackson
Laboratory campuses in Maine and Connecticut. To disseminate the curriculum broadly, we will publish it as a
website under an open access license for self-study and for teaching. By building, testing, and disseminating
an openly accessible curriculum in experimental design and statistics, we expect to build statistical fluency
among biomedical researchers. By building this fluency, we expect these researchers to find new insights into
the complexity of human disease. As a result biomedical studies will have more power to uncover mechanisms
and processes, which will accelerate progress in human disease research.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This project will create a curriculum to train biomedical researchers in experimental design and statistics using the statistical programming language R. The curriculum will allow biomedical researchers to engage in sound and reproducible experiments, which will accelerate progress in understanding and treating human disease.